Exploration of the unique neurobehavioral profile of sequential opioid-stimulant polysubstance use disorders

Among drug users, polysubstance use is much more common than single substance use. One of
the deadliest combinations of substances used in America today is concurrent opioid and
stimulant usage, with co-use of these drugs becoming increasingly responsible for overdose
deaths. Out of the 2.1 million Americans which had an opioid use disorder (OUD) as of 2017, 11%
also had a methamphetamine use disorder. First-time methamphetamine use is more likely after
past-month opioid use. Additional research into the neurobiology of polysubstance use is
essential for the development of targeted, effective treatments for polysubstance addiction.
Addiction behaviors arise from neuroplasticity within the neural circuits responsible for decision -
making, motivation, and reward processing. Individually, stimulants and opioids have different
actions within these circuits, each targeting distinct regions, receptors, and neurotransmitter
systems. Because of this, many of the cellular and molecular adaptations induced by these two
drug classes are unique. Yet, it is unclear how the interaction of these compounds within the
nervous system produces changes in drug-seeking and taking behavior. The proposed study will
explore the neurobehavioral effects of dual opioid and methamphetamine use disorders. The
following Aims will guide the proposed study. AIM 1 is to define the behavioral profile of dual
opioid-methamphetamine use disorders in a rodent model of addiction. Despite its rising
popularity, the underlying behavioral patterns and motivations of polysubstance addiction are not
well characterized. Therefore, the first aim will compare and contrast polysubstance and mono
substance addiction behavioral patterns (i.e. drug-seeking, drug-taking, and reward valuation)
using a reverse-translational rodent self-administration model. AIM 2 is to map neural activation
patterns within the cortico-basal ganglia-thalamic (C-BG-T) circuit in response to opioid and
methamphetamine self-administration. Alterations in the C-BG-T networks contribute to addiction
behaviors, as well as the persistence of individual substance use disorders for both opioids and
stimulants. Yet, it is still unclear how chronic, sequential polysubstance use alters neurocircuit
activity. Therefore, the proposed study will map neurocircuit activation patterns with a novel viral-
mediated gene transfer approach for post-mortem tissue analysis, whole brain lightsheet
microscopy, in order to identify differences in C-BG-T network activity between animals with a
history of chronic polysubstance or single substance use. We hypothesize that opioid-stimulant
polysubstance use will have a unique, synergistic effect on addiction-related behaviors and neural
circuit recruitment that is not present when either drug is used alone.

Public health relevance
One of the deadliest combinations of drugs used in America today is concurrent opioid and stimulant usage, with polysubstance use responsible for the vast majority of overdose deaths. This project will investigate addiction- like behavioral phenotypes unique to polysubstance use disorders and their underlying neural circuits, using a combination of fentanyl and methamphetamine self-administration and whole brain light sheet microscopy. Together, these findings will provide insight into the neural basis of polysubstance addiction and will have the potential to inform the development of targeted, effective pharmacotherapeutics for the treatment and prevention of polysubstance use disorders.